Enabling rapid and effective stroke thrombectomy procedures from a Transradial approach: Combining introducer sheath, guide catheter, and distal access catheter into a single device.

PROJECT SUMMARY/ABSTRACT
This proposal will improve the care of patients suffering from Acute Ischemic stroke (AIS). Catheter-based
thrombectomy has been established as the standard treatment for AIS. Still, substantial limitations remain: <50%
of patients achieve first-pass clot clearance, the best predictor of good neurological outcome, largely due to
shortcomings in the approach (transfemoral access [TFA]) and the current catheters used to aspirate clots.
Given the advanced age of many or most thrombectomy candidates, highly tortuous vessels are frequently
encountered when traversing from the femoral to carotid territories. It has been shown that substantial
tortuosity leads to worse outcomes in TFA procedures. Thus, many leading interventionalists have proposed
transradial access (TRA) in place of transfemoral access. TRA is already the preferred access site for the vast
majority of interventional cardiology procedures, given low rates of bleeding complications and ready access to
the coronary circulation. The radial site also provides ready access to the cerebral vasculature, bypassing
tortuosity along the aortic arch, descending aorta, and ilio-femoral system. However, neurointerventionalists
who use TRA are stuck employing femoral guide sheaths (such as the Ballast or Neuron Max), which are not
designed for the radial-to-intracranial navigation and which have safety concerns due to the vasospasm or
radial artery occlusion that can result from their imperfect adaptation to TRA.
A parallel advancement in neurointervention is that of SuperBore Distal Access Catheters (DACs) used to
efficiently pull out clots from arteries of patients suffering from AIS. These SuperBore DACs provide large
lumens (increasing suction by >30% over conventional DACs), but struggle with navigation challenges in
tortuous anatomies, with nearly half of procedures resulting in failure to navigate to the clot face. While they
provide a major advance in DAC sizing, SuperBores have not been considered for TRA approaches due to
their thick walls and stiff tips, precluding the ability to achieve optimized navigation or suction power from the
radial approach. Our team discovered this pressing need after achieving acquisition by Medtronic of our
previous SBIR-funded program via intensive interviews of 50+ physicians.
In our successful Phase I project, we developed and tested our novel SuperBore thrombectomy system
appropriate for TRA. Specifically, our “Wrist-to-Brain” thrombectomy system provides the distinct advantages
of: (1) combining guide catheter and SuperBore DAC in a single catheter, (2) hyperthin walls enabled by our
novel, proprietary liner, and (3) a highly trackable and kink resistant shaft that still fits within the radial artery in
most patients. In this Phase II SBIR program, we propose a full, formal validation program guided by FDA
testing criteria (Aim 1), followed by extensive benchtop, GLP animal, and cadaveric testing (Aim 2). This grant
will enable us to complete all testing needed to submit for FDA clearance and begin marketing our novel and
impactful Wrist-to-Brain thrombectomy system in order to improve the care of patients suffering from LVO AIS.

Public health relevance
PROJECT NARRATIVE In this Phase II program, we will test the novel ‘wrist-to-brain’ system that provides optimal navigation characteristics to rapidly remove blood clots from arteries in patients suffering from severe stroke. Using a novel hyperthin liner system, our device will improve patient outcomes by allowing the use of the radial artery in the wrist rather than the femoral artery, a crucial capability in elderly patients who have hardened and tortuous arteries. The in vitro, cadaver, and animal testing in this grant will prove the effectiveness and safety of the device and provide all data needed to submit for FDA clearance of this physician-driven innovation.